Cell Sorting Facility

PROJECT SUMMARY/ABSTRACT – SHARED RESOURCE: CELL SORTING FACILITY
The Cell Sorting Facility (CSF) provides FCCC members access to and technical support for the technology of
flow cytometry, a method for analyzing and isolating (sorting) cells in a complex mixture, based on a variety of
parameters, including light scatter and fluorescence. The CSF is under the direction of Co-Directors Kerry
Campbell, PhD (CSM) and Joan Font-Burgada, PhD (CSM) and supported by four staff members. The primary
goal of the CSF is to provide FCCC members with the highest quality analytic and sorting capabilities. In addition,
the flow cytometry-based services of the Human Immune Monitoring component (previously a developing Shared
Resource under the co-direction of Campbell) were recently incorporated into the CSF to provide human
immunology expertise and a dedicated team performing correlative analyses of immune phenotype and function
on samples from patients to support immunotherapy clinical trials and research at FCCC. As flow cytometry
technology has matured, it has become an essential component of research, utilized in a diverse array of
laboratories. 42 FCCC members used the CSF in the 12 months ending 10/31/23 with 74% of service hours
supporting peer-review funded research. 57 FCCC members from all three Research Programs used the CSF
from 2019-2023 (October). The CSF services are best facilitated though a centralized facility, due to the
complexity, cost and caliber of the instrumentation, as well as the need to quickly analyze perishable live cells.
The combined 42 years of experience and expertise of Campbell and Font-Burgada is key in implementing
state-of-the-art technology and innovative approaches. Since 2019, the Institution provided over $1.5 million to
purchase new equipment and $122,580 to renovate a new CSF laboratory. The new equipment will deliver next
generation service for many years to provide multi-omic single cell analysis capabilities. The CSF currently
comprises an impressive collection of six flow cytometers: 1) a user-operated BD-LSR II analyzer, 2) an operator-
run BD FACSAria II sorter, 3) another operator-run BD FACSAria II sorter in a biological safety cabinet to analyze
unfixed human samples, 4) a user-operated Symphony A5 analyzer, 5) a user-operated BD FACSMelody sorter,
and 6) an operator-run BD FACSymphony S6 spectral sorter/analyzer housed in a biological safety cabinet for
biohazardous samples. In addition, a new Isoplexis IsoSpark unit performs single cell proteomics assays. The
Flow-LIMS and Path-LIMS data management systems were developed by the PSF to allow all FCCC members
to annotate, access, and manage flow cytometry data remotely and to facilitate sharing of experimental data,
which fosters collaboration between laboratories. The CSF is advised by a dedicated Facility Advisory Committee
and the Facility Parent Oversight Committee, which together serve to ensure that the CSF continues to have the
necessary resources to provide the highest quality services.